Dissemination Core

Project Summary
The Dissemination Core (DC) is a crucial component of the success of CREATE. The DC advances the
Center’s mission of ensuring that the benefits of technology can be realized by older adults to support and
enhance their independence, productivity, health, safety, social connectedness, and quality of life. The DC
promotes CREATE scientific outcomes, design guidelines, products, tools, and protocols to a broad
constituency using a variety of dissemination methods (e.g., book series, website, workshop, webinars, social
media, publications, and presentations). The major aims of the core are to coordinate and direct dissemination
activities to maximize the impact of CREATE work. Specifically, for CREATE V, activities will include
capitalizing on existing connections to networks, agencies, and communities to promote CREATE activities
and research; formalizing dissemination efforts to inform stakeholders; enhancing translational efforts targeted
to industry and international groups; and systematically advancing social media and internet presence. The DC
will continue to deploy successful dissemination strategies and techniques developed over the past two
decades that have resulted in the Center and PIs receiving awards for innovative and interdisciplinary
research, publishing hundreds of peer-reviewed journal articles, presenting at most major aging, psychology,
and design conferences and hosting well-attended and well-received webinars and workshops nationally and
internationally. CREATE V dissemination activities will specifically target stakeholders who work with and have
the ability to improve the health and wellbeing of older adults, including healthcare networks; the industry and
design community; community and government agencies; the scientific community; and older adults and the
general public. The DC has developed and will monitor metrics of success associated with reaching each of
these stakeholders. In addition to previously deployed methods and strategies, CREATE V will develop new
materials and strategies to reach a broad array of stakeholders, including podcasts and “Research in a Minute”
web videos targeting different stakeholders; policy briefs targeted at local and national governments; news
materials, action plans, and public-facing articles in conjunction with existing professional connections of
CREATE PIs; and formalized efforts to inform stakeholders. Another new structure of the DC for CREATE V is
the development and implementation of a social media internship program. The DC will also take advantage of
CREATE’s new Industry Advisory Council (IAC) to disseminate CREATE findings and products to small and
large businesses; designers and programmers; workplace managers; and human resources departments. Our
efforts to inform older adults, healthcare providers, family members, and the community at large will reduce
age-stereotypes, especially myths about older adults’ interest in innovative technology use. Traditional and
novel dissemination routes will help ensure the goals of minimizing technology disparities and bridging the
digital divide are met, allowing individuals of all ages to benefit from existing and emerging technologies.